Modeling Metastasis and Acquired Drug Resistance Using Circulating Tumor Cells

Project Summary
Advanced estrogen receptor (ER)-positive breast cancers are initially responsive to multiple therapeutic
interventions, but they ultimately develop drug resistance and disseminate to multiple metastatic sites.
Circulating tumor cells (CTCs) underlie the blood-borne spread of cancer and they also provide a
noninvasive source to sample, monitor and analyze tumor evolution in real time, as patients develop
progressively resistant disease with new metastatic lesions. To enable the detailed molecular study of
CTCs, which are extremely rare cells in the circulation, we have made use of microfluidic platforms that
efficiently deplete normal hematopoietic cells from blood specimens, leaving behind an enriched
population of intact CTCs, some of which remain viable. During the past funding period, we established a
panel of patient-derived breast cancer CTC cell lines (Yu et al., Science 2014), which provide a window into
critical and poorly understood properties of advanced breast cancer, with significant clinical implications.
We demonstrated that these heterogeneous ER+ drug-resistant breast cancer cells contain distinct
phenotypes, with a HER2-expressing proliferative state interconverting spontaneously with a Notch1-
driven drug resistant state (Jordan et al., Nature 2016). In Aim 1, we will build on this observation to define
the likely epigenetic mechanisms that modulate this phenotype conversion. Using live-reporter constructs,
we will isolate single cells as they switch between phenotypes to define early transcriptional changes, and
in bar-coded pooled knockdown screens, we will test how chromatin modulators affect this phenotype
switch, both spontaneously and following the dramatically enhanced reactive oxygen species (ROS)-
mediated conversion that we have observed. In Aim 2, we will study another unexpected observation
made with cultured breast CTCs, namely their acquired quiescence following direct intravascular
inoculation and dissemination to the lung. While a 200 CTC inoculum can initiate tumorigenesis in the
mammary gland, tail vein inoculation of 200,000 CTCs leads to non-proliferative single cells throughout
the lung, an observation that may be linked to ROS stress experienced by these cells in the bloodstream
(Zheng et al., Nature Comm, 2017). We have used pooled bar-coded knockdown construct libraries of
chromatin modulators to uncover candidate regulators that are enriched as CTCs eventually initiate
proliferation in the lung, and these will be tested individually and in combination, validated in multiple CTC
lines, and matched with RNA seq transcriptomes of early stages in the transition from quiescence to early
proliferative metastatic lesions. In Aim III, we will examine organ-specific pathways that enable
proliferation of breast CTCs in the brain versus bone or liver. By serial inoculation, we have generated
derivative lines of CTCs that grow efficiently following direct implantation in brain, compared with parental
cells which exhibit a prolonged delay. Using both RNA sequencing and whole proteome mass
spectrometry, we will identify modulators of organ-predominant metastasis, which will then be validated
through functional assays and correlated with primary CTCs from patients with organ-predominant
metastases. All together, these experiments will use patient-derived cultures of metastatic precursors to
better understand and ultimately target breast cancer progression.

Public health relevance
Project Narrative Primary and metastatic cancers shed cells into the bloodstream. These circulating tumor cells (CTCs) underlie the blood-borne spread of cancer, and they also provide a noninvasive source of cancer cells for monitoring response, progression and acquired drug resistance during the course of therapy. We have established primary cultures of CTCs from women with advanced drug-resistant estrogen receptor (ER)- positive breast cancer, and have shown that these comprise heterogeneous cell populations, capable of switching between proliferative (HER2+) and drug resistant (Notch1+) phenotypes. Moreover, cultured human CTCs exhibit striking differences in tumor initiation in mouse models: highly tumorigenic following orthotopic organ inoculation but primarily quiescent after direct intravascular inoculation. We propose to determine key regulators of CTC-derived tumorigenesis, using a combination of RNA and proteomic profiling, pooled bar-coded knockdown libraries, and reconstituted mouse models, followed by validation of candidate genes and pathways in primary human CTCs.